Training Grant in Cardiovascular Research

SUMMARY
The Cardiovascular Research Training Program at Brigham and Women's Hospital aims to
prepare trainees for independent careers in investigative pursuits. The three themes of
particular focus for this T-32 program include 1) Myocardial Cellular and Molecular Biology and
Genetics, 2) Vascular Cell and Molecular Biology, and 3) Translational/Clinical Cardiovascular
Research. We propose to strive to continue our record of preparing our trainees to develop
independent research programs, obtain faculty positions, and acquire peer-reviewed funding.
Our environment offers substantial resources to trainees, ranging from core laboratories within
Brigham and Women's Hospital, formal educational opportunities including those of the adjacent
Chan-Harvard School of Public Health, and ample resources within the individual laboratories of
faculty members. The program provides a structured program for each trainee including
formulating formal Individual Development Plans for each trainee, orientation lectures, formal
instruction in responsible conduct and professionalism in research, advanced course work,
multiple inter-disciplinary research group meetings and seminar series, and tailored and flexible
research experiences. Indeed, a historical strength of our T-32 program is working with trainees
to place them in the best laboratory and mentoring environment to meet their individual training
needs and career goals whether it be at BWH and its partner institution the MGH, or in the
broader surrounding environment including the Dana-Farber Cancer Institute, the Harvard
Medical School and Chan School of Public Health, The Broad Institute, Children’s Hospital, MIT,
the Harvard BioLabs and the Stem Cell Regenerative Biology Institute among others. Each
trainee works under the close supervision of a faculty mentor throughout their training. In
addition, a Fellowship Advisory Board oversees the program and monitors closely the progress
of trainees and their Individual Development Plans. The Research-in-Progress seminar, an
annual Fellow's Poster Session, and Cardiovascular Grand Rounds serve to highlight and
support the work of the post-doctoral trainees. We have a particular and successful commitment
to recruiting and fostering the careers of woman and minority trainees. In this renewal
application we propose to continue our longstanding record (documented within) of preparing a
talented pool of fellows for successful academic careers.

Public health relevance
NARRATIVE The Cardiovascular Research Training Program at Brigham and Women's Hospital aims to prepare trainees for independent careers in investigative pursuits. This T-32 focusses on 1) Myocardial Cellular and Molecular Biology and Genetics, 2) Vascular Cell and Molecular Biology, and 3) Translational/Clinical Cardiovascular Research. Our environment offers substantial resources to trainees to ensure continuation of our longstanding record of preparing a talented pool of trainees for productive independent research careers.